Multiplexed Analysis of the Epitranscriptome

Project Summary/Abstract
Epitranscriptomics is the study of RNA modifications, which include more than 170 naturally occurring chemical
alternations to the nucleotides. More than 60 are found in human RNA of all types: mRNA, tRNA, rRNA, lncRNA,
and the others. These modifications are dynamic; their global quantities change in development and during
disease progression. They are installed by writer enzymes, read by reader proteins and removed by eraser
enzymes, and they have an intrinsic capacity to alter RNA structure and dynamics. They influence translation
initiation and termination, translation fidelity, alternative splicing, trafficking between cellular compartments, and
regulate RNA degradation. RNA reader, writer and eraser proteins are promising drug targets of high current
interest to pharma. Currently available analytical methods either do not report on sequence context or provide
sequence information but at the expense of multiplexing capability. Despite these limitations, it is now known
that modifications are dynamically tied to phenotypic changes in cancer progression, drug resistance, aging, and
viral infection. Alida Biosciences is developing a new commercial platform to detecting, identifying, and mapping
RNA modifications in a multiplex and with high sensitivity—suitable for clinical samples (e.g. needle biopsies,
FFPE samples) in which low quantities of RNA may be available. Following completion of our Phase I milestones
focused on creating the new multiplexed assay and proof-of-concept testing, this proposal aims to (1) complete
assay development, optimizing sensitivity, specificity, and a robust and user-friendly workflow, (2) develop assay
automation, and (3) perform assay validation in preparation for commercial launch. This technology will be
significant because it will provide the first commercial platform capable of profiling and correlating changes of
multiple RNA modification types across the entire transcriptome in a given sample.

Public health relevance
Project Narrative Alida Biosciences is a start-up company focused on reading the epitranscriptomic code, a regulatory layer of biological information controlling how the genetic code is used in cells in health and in disease progression. By creating and commercializing the first platform for reading multiple elements of this epitranscriptomic code simultaneously, we will enable new science to understand the progression of diseases such as cancer and accelerate drug development targeting epitranscriptomic pathways.